CORE--LESION INDUCTION FACILITY

The Lesion Induction Core is designed to support all projects requiring animals with induced developmental malformations of the cortex. Thus all experiments from all projects that require mice or rats with either induced microgyria Or induced molecular layer ectopias will be generated by this core. This centralized core devoted to the induction of anomalies will help to ensure uniform lesions for all experiments in all projects.